Facilitating an International Workshop on HIV, Sexual Reproductive Health, & Adolescence (IHSRHA)

Abstract
Now in its 9th year, the International Workshop on HIV, Sexual Reproductive Health, & Adolescence
(IHSRHA) provides a collaborative platform to advocate for youth engagement in HIV research. The workshop
is held annually in a different African country, to encourage attendance from high-HIV-burden countries and
reduce travel and visa barriers for target attendees. The global community seeks to end the HIV epidemic by
2030 using the 95-95-95 strategy. This will require sustained collaboration between diverse actors in Africa,
including young people attending the workshop, using evidence-based interventions (EBIs) and dissemination
and implementation (D&I) science strategies and frameworks to reduce silos in knowledge and close the
research-to-practice gap. As a result, we propose to organize for the next 5 years, a workshop within IHSRHA
aimed at D&I directly, by bringing leading D&I researchers and fostering youth capacity in D& I science to
advocate for evidence-informed policy and research aimed at ending the HIV epidemic in Africa. Using Youth
Participatory Action Research which considers young people as experts of their own experiences and
facilitates their involvement as co-creators of knowledge and Knowledge to Action Framework which facilitates
the use of research knowledge by several actors, including young people themselves, our specific aims are;
1) (Pre-Conference) Implement an HIV-related dissemination and implementation (D&I) science pre-
conference course for adolescents and young people, including five youth fellows recruited via participatory
approaches, to accelerate action to end the AIDS epidemic by 2030; 2) (Conference) Convene an in-person
conference of key actors to deliberate on and inform the implementation of contextualized HIV EBIs for
adolescents and young people using D&I frameworks and strategies to advance the 95-95-95 strategy in
Africa; and 3) (Post-Conference) Initiate and accelerate scientific progress through youth-driven dissemination
products and formation of virtual participatory learning committee to sustain youth engagement.
We expect findings of the workshop to help accelerate efforts to end the HIV epidemic Africa using context-
specific D&I strategies and frameworks as led by young people for young people.

Public health relevance
Project Narrative HIV remains a major cause of preventable mortality in young Africans, despite available evidence-based prevention and treatment interventions. The proposed workshop will have a profound impact with accelerating efforts to end the HIV epidemic for young people using evidence-based interventions and dissemination and implementation science frameworks and strategies applicable to Africa. It will also serve as a valuable investment and sustainable infrastructure to support the pipeline of new youth researchers developing careers in HIV dissemination and implementation science research in Africa.